PIK3CA signaling and pancreatic cancer

The goal of this proposal is to explore how to target PIK3CA signaling for treatment of pancreatic ductal
adenocarcinoma (PDAC). This deadly cancer is highly resistant to current treatment regimens, including
immunotherapy with checkpoint inhibitors. More than 90% of PDAC have oncogenic mutations in KRAS, and
PIK3CA is a direct effector of KRAS. Our group first reported that genetic ablation of PIK3CA in the pancreas
completely protected mice against oncogenic KRAS-induced tumor formation, and subsequently reported that
PIK3CA plays a critical role in sustaining pancreatic tumors by shielding them from the immune system.
Orthotopic implantation of KrasG12D;Trp53R172H;Pdx1-Cre (KPC) pancreatic tumor cells in immunocompetent
mice caused 100% lethality, whereas mice implanted with Pik3ca-/- KPC (PIK3CA-KO) KPC cells exhibited
tumor regression with 100% animal survival. A genome-wide gene deletion screen to search for molecules that
can reverse the elimination of PIK3CA-KO cells by the immune system identified PCCB, which catalyzes the
carboxylation of propionyl-CoA to produce methylmalonyl-CoA. PCCB-null PIK3CA-KO KPC cells were
generated, and when implanted in mice, these tumors were not cleared by the host immune system. Two
hypotheses will be tested: 1) Oncogenic KRAS activation of PIK3CA modulates a PCCB-regulated metabolic
environment that favors evasion of pancreatic cancer from immune elimination; and 2) Alpelisib inhibition of
PIK3CA enhances the activity of anti-PD1 plus anti-PCSK9 therapy against pancreatic tumors. Aim 1
investigates mechanisms by which KRAS activation of PIK3CA modulates a PCCB-regulated metabolic
environment that favors immune evasion of pancreatic cancer, including upregulation of immune checkpoints
and T cell exhaustion. Tumor infiltrating T cells will be isolated and analyzed by single-cell RNA and T cell
receptor (TCR) V(D)J sequencing, flow cytometry and IHC. Adoptive T cell transfer experiments will be
performed to determine if T cells previously exposed to PCCB-null PIK3CA-KO tumors will eliminate PIK3CA-
KO tumors implanted in SCID mice. Cell metabolism and immunological profile of PCCB-null PIK3CA-KO vs.
PIK3CA-KO and parental KPC cell lines will be measured to better understand the metabolic alterations
controlled by PIK3CA and PCCB and how these changes may lead to immune suppression. Aim 2 is a
therapeutic study that tests the efficacy of alpelisib, a PIK3CA inhibitor, in combination with neutralizing
antibodies against PD-1 and PCSK9 for treatment of pancreatic cancer using the orthotopically implanted KPC
mouse model. Tumor infiltrating T cells will also be isolated and analyzed by single-cell sequencing. In
summary, this proposal will investigate how PIK3CA signaling regulates the metabolic and immunological
profile of pancreatic cancer. Alpelisib, anti-PD1 antibodies and anti-PCSK9 antibodies are all FDA-approved for
clinical use. Successful completion of our studies may lead to clinical trials with these approved drugs for
treatment of pancreatic cancer.

Public health relevance
Pancreatic cancer causes approximately 40,000 deaths every year in the U.S.A. and currently there is no effective treatment for tumors that cannot be surgically removed. More than 90% of human pancreatic cancers are caused by mutations in a protein named KRAS that works together with another protein called PIK3CA to promote cancer growth. The goals of this proposal are to clarify how PIK3CA causes pancreatic cancer progression and to test whether a drug that blocks PIK3CA can be used to treat this deadly disease.